Enhancing the Implementation, Effectiveness, and Reach of Geriatric Emergency Departments for Older Adults with Dementia (EMERGED)

PROJECT SUMMARY/ ABSTRACT
One in four of the 6 million U.S. older adults with Alzheimer’s and related dementias (ADRD) is hospitalized
from the Emergency Department (ED) each year. Evidence shows 11% of these ED hospitalizations are
potentially avoidable; however, few interventions have effectively reduced ED hospitalizations among older
adults with ADRD. Geriatric Emergency Departments (GEDs) are an innovative care delivery intervention
shown to reduce ED hospitalization rates. However, the limited understanding of how GEDs work across the
U.S., what care processes are most effective, and how best to implement GEDs are critical barriers to the
continued adoption of this promising new intervention. To overcome these barriers, we will link national
Medicare claims to detailed GED accreditation data to determine specific care processes associated with
avoidable hospitalizations and identify best practices for GED implementation. We have assembled a team of
experts in in emergency medicine, geriatrics, implementation science, and organizational behavior and
developed a strategic research-practice partnership with the GED Accreditation program that will allow us to
study GEDs with unprecedented depth and impact. In Aim 1, we will identify GED care processes adopted at
high-performing GEDs with the largest reductions in hospitalizations and increases in hospital-free days within
30 days among older adults with ADRD. Next, we will use qualitative methods to compare barriers, facilitators,
and organizational factors associated with GED implementation among high-performing GEDs, low-performing
GEDs, and non-GEDs (Aim 2). Finally, we will translate our findings into a toolkit of feasible and high impact
implementation strategies in partnership with the GED Accreditation program (Aim 3). Successful completion of
these aims will result in a comprehensive understanding of effective GED care processes and an actionable
toolkit of strategies to improve GED implementation and reduce avoidable hospitalization among older adults
with ADRD. Our work is impactful and innovative because we will translate our findings to real-world outcomes
using a research-practice partnership; apply expertise in organizational change to accelerate innovation
adoption; and use novel, rigorous causal inference and implementation science methods. This proposal
directly advances NIA ADRD milestones 13N and 13P to elucidate the mechanisms of health care utilization
and quality and evaluate the impact of policies on persons living with ADRD and responds to the Notice of
Special Interest (NOT-AG-21-046) on programs and services for persons with dementia. Our findings will
inform future GED guidelines and catalyze the evidence-based adoption of care delivery innovations to reduce
avoidable hospitalizations for the millions of older adults with ADRD who experience ED visits annually.

Public health relevance
PROJECT NARRATIVE One in four U.S. adults with Alzheimer’s and related dementias (ADRD) is hospitalized from the Emergency Department (ED) each year; however, a substantial proportion of these hospitalizations may be avoidable. This study examines Geriatric Emergency Departments, a novel care delivery intervention that reduces ED hospitalization rates among older adults, by identifying factors associated with avoidable hospitalization and effective implementation. By identifying and disseminating best practices for GED success, this project will reduce avoidable hospitalizations among the millions of older adults with ADRD who visit U.S. EDs annually.